Epidemiologic Studies

Summary. Sub-Project 3 (Epidemiology: genes, modifiable risk factors, and risk prediction for breast cancer) will extend existing genome-wide association studies (GWAS) as well as the additional discovery efforts in Sub-Project 1 of this application by characterizing the relationships among newly-discovered common breast cancer risk alleles, known breast cancer risk factors, and breast cancer incidence. This Sub-Project will accelerate the translation of GWAS findings to clinical and public health practice by suggesting particular biologic mechanisms for breast cancer etiology (Aims 1-3) and by evaluating the clinical validity and utility of genetic risk prediction models in a variety of settings (Aims 4-6). The Sub-Project encompasses six specific aims: 1) Conduct a GWAS for new loci that interact with other, known breast cancer alleles; 2) assess gene-gene interactions among known breast cancer risk alleles; 3) assess gene-environment interactions between known breast cancer risk alleles and established risk factors, most notably modifiable exposures such as postmenopausal hormone therapy; 4) construct and compare the clinical validity of risk prediction algorithms that combine information on multiple breast cancer alleles and known risk factors; 5) evaluate the performance of these algorithms in high-risk families; and 6) assess genetic modification of prophylactic tamoxifen treatment.

Public health relevance
RELEVANCE (See instructions): This Sub-Project will accelerate the translation of GWAS findings to clinical and public health practice. It will generate hypotheses regarding the basic biology of breast cancer, which can be investigated in Sub-Project 2 of this proposal. A deeper understanding of breast cancer biology may eventually lead to better prevention and treatment strategies for breast cancer, which kills over 40,000 U.S. women every year. This Sub-Project will also generate risk prediction algorithms and new information about women who may be more likely to benefit from tamoxifen chemoprevention or hormone therapy, which could have immediate clinical and public health applications.